Population genetic methods to detect population structure and adaptation using modern and ancient genomic datasets

ABSTRACT
Detecting adaptive genetic variation in population genomic datasets is important for understanding the genetic
architecture underlying complex genetic diseases. Humans and other natural populations have been evolving
under complex demographic histories, including divergence of ancestral populations, migration in structured
populations, and past population size changes. Adaptive genetic variation and variation subject to complex
demographic histories can result in similar observable genomic patterns, and distinguishing the evolutionary
forces underlying genetic variation observed in natural population remains challenging. It is thus of importance
to unravel the complex demographic histories underlying natural populations, and develop methods that detect
adaptive genetic variation while properly accounting for these histories. In addition to contemporary genomic
data, researchers have been gathering genetic data from ancient human remains in recent years. Including
such datasets into the analyses has the potential to vastly improve our ability to detect population structure and
genetic variation adapting to selective pressure. Thus, we will develop several tools for the analysis of
contemporary and ancient genomic datasets to unravel the migration histories underlying the population
expansion of humans and to detect adaptive genetic variation while accounting for these histories. To this end,
we will develop a novel Coalescent Hidden Markov Model method to characterize complex migration histories.
Our novel approach will use more efficient representations of local genealogies then previous approaches,
which increases the accuracy of the inference and is more robust to noise in the data. Moreover, this
framework will allow us to analyze population genomic data from large public databases to identify adaptive
genetic variation. The local genealogies will be highly skewed in regions with adaptive genetic variation, as
compared to genomic regions evolving under neutrality. The novel framework can be used to compute the
posterior distribution of genealogical summaries at different locations in the genome to identify regions with
skewed genealogies. In addition, we will implement approaches to detect adaptive genetic variation based on
forward-in-time solutions of the dynamics of beneficial genetic variation and linked neutral regions. Based on a
previously developed numerical approach, we will develop composite likelihood frameworks of observed
genomic sequence variation under this model to detect adaptive genetic variation, while accounting for the
underlying complex demographic history. Moreover, we will develop a method that aims at detecting polygenic
adaptation from ancient DNA. This approach will be based on explicit likelihood models of the underlying allele
frequency dynamics and allow us to detect and quantify directional and, unlike previous approaches, stabilizing
selection on complex traits. Lastly, we will collaborate with colleagues to apply these methods and other
appropriate tools to ancient DNA datasets to unravel the genetic response of medieval European populations
to the Black Death pandemic.

Public health relevance
PROJECT NARRATIVE In the proposed project, we will develop and apply population genetic tools to detect and disentangle signals of population structure and adaptation in contemporary and ancient genomic datasets. Identifying monogenic or polygenic adaptive genetic variation is a key step towards understanding the genetic mechanisms affecting disease prevalence in different population groups and unraveling the genetic architecture underlying complex genetic diseases. The tools will use explicit models of the underlying population genetic processes to detect the genomic patterns characteristic to complex migration histories and adaptive genetic variation.